Reprogramming and Directed Differentiation of Skeletal Muscle Cells from hPSCs

ABSTRACT
In the most prevalent muscular dystrophy, Duchenne Muscular Dystrophy (DMD), repeated muscle
degeneration and regeneration leads to muscle satellite cell (SC) dysfunction and/or exhaustion and there is
no cure. In the previous funding period, we have identified novel differentiation and enrichment strategies to
generate the most engraftable cells to date from human induced pluripotent stem cells (hiPSCs), as well as a
CRISPR correction strategy to restore dystrophin applicable to 60% of patients. The next phase of this work is
now focused on improving our understanding of the functional status of skeletal muscle progenitors (SMPCs)
derived from wt, DMD and CRISPR corrected lines. This work will improve our understanding of the molecular
and differences between human PAX7+ stem cells and progenitor cells across human fetal development
through adulthood, and inform our ability to generate the most regenerative cells from hiPSCs in this funding
period. In Aim 1, we will define human SMPCs and SCs arising in development and from hiPSCs and identify
functional differences between progenitor and SC states across human development and in vitro derived cells
using single cell sequencing and evaluation of candidate pathways different between SMPC and SC states. In
Aim 2, we will evaluate the role of the host microenvironment including endogenous PAX7 cells on stem cell
engraftment and ability to transition to SCs and reside in the SC niche. In Aim 3, we will utilize DMD and
isogenic CRISPR/Cas9 SMPCs/SCs to evaluate specification, cell biology and functional potential of DMD and
CRISPR corrected cells in diseased mdx-NSG and mdx-D2-NSG microenvironments. This will improve our
understanding of differences and transitions between human muscle progenitor and stem cell states and will
improve our ability to generate cells capable of repopulating the niche in long term studies.

Public health relevance
PROJECT NARRATIVE Skeletal muscle progenitor cells (SMPCs) and satellite cells (SCs) participate in muscle growth and regeneration in fetal and adult development, respectively. In human, the transition of SMPCs to SCs during development is poorly understood. Human induced pluripotent stem cells (hiPSCs) offer enormous potential for understanding human myogenesis including the transition of progenitors to adult SCs. Generation of the most regenerative SMPC or SC-like cells from hiPSCs could also improve our ability to model muscle diseases in a dish and have the potential for use in personalized cell replacement therapies.